Understanding the role of molecular chaperone systems in protein aggregate disassembly

PROJECT SUMMARY
Protein aggregation is associated with both neurodegenerative and systemic diseases such as
Alzheimer’s disease, ALS, and Transthyretin amyloidosis. Highly ordered aggregates known as amyloids
underlie these disease pathologies. Proteins can also undergo liquid-liquid phase separation to form
amorphous aggregates that assemble into biomolecular condensates. Proteins within condensates are
dynamic and reversible. However, with age and stress, persistence of proteins within these condensates can
lead to solidification and formation of irreversible aggregates associated with disease. Our LONG-TERM GOAL is
to understand how cells manage protein aggregates. It is well established that molecular chaperones play a
critical role in the disassembly of both condensates and amyloids. However, the field is beginning to unlock the
mechanisms in which chaperones mediate this disassembly. Two different chaperone systems have been
identified to have “disaggregase” activity. Hsp110 is a highly conserved nucleotide exchange factor that binds
with members of the Hsp70 family for disaggregation. The Hsp104 system also binds with the Hsp70 family
chaperones to disassemble and fragment protein aggregates. It has been suggested that these two systems
may work together to increase disaggregation efficiency. Understanding the mechanisms that underlie this
synergy will provide significant leverage into developing therapeutic directions for treating neurodegenerative
and systemic protein aggregation diseases. The OBJECTIVE OF THIS PROJECT is to define how Hsp110 and
Hsp104 systems work together, whether in parallel or in concert, to manage different types of protein
aggregates. Due to strong conservation of chaperone systems across eukaryotic systems, a yeast-based
model provides a tractable system for undergraduate researchers to study molecular mechanisms that underlie
protein disaggregation. The goal of this proposal is to understand how Hsp104 and Hsp110 chaperone
systems manage protein disaggregation using three different protein aggregation systems: A) the study of
biomolecular condensates: stress granules, B) the study of human amyloid: Transthyretin protein, and C) the
study of a yeast-specific amyloid: [PSI+]. This multi-pronged approach provides the ability for controlled
exploration of how these two chaperone systems coordinate their efforts to manage different protein aggregate
substrates. This approach will provide important understanding of how chaperone systems efficiently and
quickly manage protein aggregates, and how they may be exploited for the treatment of protein aggregation
diseases.

Public health relevance
PROJECT NARRATIVE Protein aggregation is associated with diseases such as Alzheimer’s disease and ALS, as well as biologically functional biomolecular condensates. Our project focuses on how molecular chaperones manage both types of aggregates. Understanding these important molecular mechanisms will broadening our general understanding of protein aggregation and uncover new avenues for chaperone-based therapies to treat these fatal diseases.